Core B: Gene Modulation with RNAi and CRISPER

PROJECT SUMMARY-CORE B
Core B supports every project within the Program by providing access to state-of-the-art CRISPR-Cas9 and
RNAi tools. Short hairpin RNAs (shRNAs) were developed with the support of this program, and ongoing
innovations by Core B and Program investigators have helped to make these extremely powerful biological
tools. During the past funding period, the Core devised a novel algorithm for predicting shRNA potency, which
led to the generation of a 5th version of RNAi libraries corresponding to annotated protein coding genes in
humans and mice. Technology has also been developed for using CRISPR-Cas9 screening to expose
functionally important protein domains. During the upcoming period of requested support, the Core proposes to
aid Program investigators through five general aims. First, the program will continue providing access to state-
of-the-art RNAi vectors and CRISPR-Cas9 vectors and procedures for analyzing either single gene
knockdowns or for performing pooled RNAi/CRISPR screens. Second, the Core will provide Program
investigators with access to the mouse and human version 5 shRNA library and will compile sub-libraries upon
request. Third, the Core will construct custom CRISPR-scanning libraries for performing structure-function
analysis on genes of interest within each Program. Fourth, the Core will produce custom domain-focused
CRISPR libraries to allow for interrogation and discovery cancer drug targets in various contexts. Fifth, the
Core will carry on its efforts to improve CRISPR-Cas9 technologies, and make those innovations available to
the Program and to the scientific community at large.

Public health relevance
PROJECT NARRATIVE- CORE B Core B will provide Program investigators with a suite of newly developed genetic tools for studying basic molecular mechanisms and for exposing novel vulnerabilities in cancer cells. In particular, the CRISPR-Cas9 methodology provided in this Core provides an innovative method for cancer drug target discovery and exposing functional domains of protein and non-coding RNAs.